Mechanisms of Circadian Rhythm Modulation by Metabolic Disease and Dietary Therapy

Project Summary
Circadian rhythms are a critical component of behavioral and homeostatic function in nearly every organism on
Earth, including humans. Neurological diseases such as Alzheimer's, Parkinson's, and epilepsy are often
accompanied by disruptions in circadian rhythms. In turn, this can exacerbate neuropathology symptoms and
worsen quality of life by causing insomnia, fragmented sleep, daytime hypersomnia, and perturbation of
metabolism. In fact, the links between metabolism and circadian function are becoming increasingly apparent.
Several components of the core molecular clock are redox sensitive or transcriptionally modified by
metabolites like NADPH, and mitochondria are known to exhibit circadian rhythms. Drosophila are an excellent
model organism in which to study circadian rhythms at behavioral, genetic, and neuronal level, possessing a
vast genetic toolkit and highly standardized methodology for assaying rhythmicity. We recently established that
the stable Drosophila model for mitochondrial diseases such as Maternally Inherited Leigh Syndrome, termed
ATP6[1], exhibits profound arrhythmicity in sleep/wake behavioral patterns and in specific behaviors such as
egg laying and eclosion under constant conditions, making it an excellent model system in which to study the
mechanistic links between altered metabolism and circadian rhythms. Here, we propose to determine the
mechanism by which mitochondrial disease leads to rhythm disruption by probing the molecular clock's
transcription-translation feedback loop, examining the physiology of the circadian circuit at the neuronal level,
and elucidating the consequences of perturbed bioenergetics and redox state. Importantly, we have also
recently discovered a successful treatment for the neurological consequences of mitochondrial disease in the
ketogenic diet, including significant improvement in rhythmicity. Therefore, we propose in Aim 2 to determine
the scope and mechanism by which this dietary therapy improves circadian function by examining
bioenergetics and physiology of neurons and glia, ion channel modulation in circadian neurons, altered gene
expression in the circadian circuit, and effects on the core clock. Additionally, we have found via a preliminary
genetic screen that disruption of glycolysis and of the Krebs Cycle also have a negative impact on circadian
rhythms. For example, RNAi knockdown and classical null alleles of citrate synthase have extremely poor
rhythmicity. We propose in Aim 3 to use the power of the Drosophila genetic toolkit to identify novel modulators
of circadian function in critical metabolic pathways including glycolysis, the Krebs Cycle, ketone body and lipid
metabolism, amino acid and neurotransmitter synthesis, and others. Overall, this project will contribute
significantly to our understanding of the links between metabolism and circadian rhythms in health and
neurological disease, as well as open new therapeutic avenues based on diet and metabolic targets.

Public health relevance
Narrative Disrupted circadian rhythms are often a hallmark of neurodegenerative and neurological diseases, including Alzheimer's and Parkinson's, and it is becoming apparent that mitochondrial metabolic function plays a role in this disruption. We propose to use the power of Drosophila genetics, behavior, and physiology to determine the molecular and cellular links between perturbed metabolism, altered circadian rhythms, and neurological dysfunction. Additionally, we will establish the mechanistic basis of the ketogenic diet's ability to improve circadian function in the context of mitochondrial disease.